Siderophore secretion by Mycobacterium tuberculosis

Project Summary - Siderophore secretion by Mycobacterium tuberculosis
To counteract the iron limitation in the host, Mtb secretes siderophores, small molecules with
high iron-binding affinities called mycobactins (MBT) and carboxy-mycobactins (cMBT). We
discovered that the two small membrane proteins MmpS4 and MmpS5 interact with the large
efflux pumps MmpL4 and MmpL5 to form the inner membrane components of a novel
siderophore secretion system that is different from all other known bacterial siderophore
secretion systems. This system is also used by Mtb to recycle siderophores. Interruption of
siderophore recycling by deleting the inner membrane components leads to self-poisoning of
Mtb and completely eliminates the ability of Mtb to replicate in mice. However, several
components of the siderophore secretion system are still unknown. In this proposal we will use
complimentary genetic, biochemical and biophysical methods to identify and characterize novel
proteins involved in siderophore secretion by Mtb.

Public health relevance
Project Narrative - Siderophore secretion by Mycobacterium tuberculosis To counteract the iron limitation in the host, M. tuberculosis secretes siderophores, small molecules with high iron-binding affinities. Interruption of siderophore secretion leads to self- poisoning of M. tuberculosis and completely eliminates its ability to replicate in mice. In this proposal we will use complimentary genetic, biochemical and biophysical methods to elucidate and characterize the molecular roles of novel proteins in siderophore secretion by Mtb.